Manipulation of the DNA damage response and the proteome on viral genomes during Herpes Simplex Virus (HSV) infection

PROJECT SUMMARY
Viruses harness host cellular functions to complete their infectious cycles. DNA virus infection introduces
foreign viral genomes into the host cell nucleus which can activate kinase signaling pathways that are part of
the cellular DNA damage response (DDR). Viruses have also evolved strategies to manipulate DDR signaling
to promote infection, and this can be achieved through viral-encoded ubiquitin ligases which target cellular
substrates with degradative and non-proteolytic outcomes. Herpes simplex virus type 1 (HSV-1) is a DNA virus
whose infection is enhanced by both activation and manipulation of cellular DDR pathways. Previous studies
have established that HSV-1 infection activates signaling through the ATM kinase pathway which benefits virus
replication. The viral immediate early protein ICP0 is a multifunctional protein important for stimulating gene
expression and overcoming host defenses during lytic HSV-1 infection. Among the known substrates for the
ICP0 ubiquitin ligase are regulators of the DDR network. Our understanding of the interface between HSV-1,
ICP0, and the host DDR pathways, has been constrained by prior knowledge from studies of DDR functions in
response to damage of cellular genomes. We propose that the viral responses will be better informed by
unbiased global approaches that define signaling networks and proteome changes specifically activated by
virus infection. In this application we bring together multi-modal proteomics techniques in an integrative
approach that will define ways that changes to the proteome by ATM-activated signaling and ICP0-mediated
ubiquitination alter recruitment of proteins onto viral genomes to promote expression and replication. In
extensive preliminary data, our global proteomic analysis of HSV-1 infected cells quantifies the landscape of
phosphorylation within DDR pathways, identifies ICP0-dependent ubiquitination events induced, and informs
on ways that these modify the set of host proteins associated with replicating HSV-1 viral genomes. Our data
converge on a number of protein targets and complexes which we propose function as key regulators of viral
gene expression and genome replication. Our complementary aims elucidate mechanisms by which
phosphorylation and ubiquitination combine to promote viral replication. In Aim 1 we will define the intersection
of phosphorylation and ubiquitination and determine their combined impact on the DDR during HSV-1 infection.
In Aim 2 we will determine ways that ubiquitination and ATM-signaling promote HSV-1 infection by examining
the proteins associated with viral gnomes to promote gene expression and replication. Integrating these global
proteomic approaches will highlight mechanisms leveraged by HSV-1 to overcome repression of gene
expression and facilitate productive infection. Understanding the cellular systems which control viral infection
will ultimately advance translational research towards developing antiviral therapies and interventions to
prevent infection.

Public health relevance
PROJECT NARRATIVE Herpes simplex virus type 1 (HSV-1) is a significant human pathogen, with recurrent infections that cause much suffering and lost work productivity in the US, yet there are no available vaccines and limited therapeutics. There is therefore a need to understand and thoroughly characterize the fundamentals of HSV-1 biology and how the virus overcomes host defenses to replicate and produce infectious progeny. This project will leverage proteomics techniques to define how HSV-1 harnesses cellular process such as cellular DNA damage response (DDR) signaling and the cellular ubiquitin proteasome system (UPS), to promote virus infection, and will thus define molecular mechanisms which suggest directions for developing novel antivirals.